MFRPS Development. State of Oklahoma Plan for Conformance with Manufacturing Regulatory Program Standards.

Manufactured Food Regulatory Program Standards
Oklahoma State Department of Health
Project Summary/Abstract
This grant opportunity would allow the Oklahoma State Department of Health (OSDH) to identify
any gaps in the program standards and create a plan to address those disparities. Oklahoma’s
compliance with the MFRPS standards would assist with creating a nationally integrated food
safety system that is in line with the other states that are currently enrolled in the MFRPS.
Additionally, this project will ensure consistency within our state program, ensure our staff are
properly trained, and provide mechanisms, standard operating procedures, and resources to
protect the health of the residents in Oklahoma. Enrollment in these standards and this funding
opportunity helps OSDH provide safe food to consumers which is one step closer to OSDH’s
vision of “Leading Oklahoma to prosperity through health”.
Gaps identified with the self-assessment will be prioritized by staff, and then set for project
management and review. The agencies specific aims are to maintain conformance and
continue toward gaining conformance with all standards. OSDH has a long-term goal of full
conformance with as many standards as possible. Progress will be measured with self-
assessments at the end of each award period.

Public health relevance
Manufactured Food Regulatory Program Standards Oklahoma State Department of Health Project Narrative This project supports public health by creating a national integrated food safety system with other states enrolled in the Manufactured Food Regulatory Program Standards. A standardized inspection program with written standard operating procedures, quality assurance checks, risk-based inspections, and proper training is important to ensure manufactured food is produced safely in the State of Oklahoma. These standards are science-based, comprehensive, and provide another layer of assurance that Oklahoma State Department of Health inspectors can protect the health of the Oklahoma consumer.